SYRACUSE HEMATOLOGY-ONCOLOGY CCOP

A continuation of the CCOP grant will enable Hematology-Oncology Associates of Central New York, P.C. (HOACNY) to continue its active participation in a wide variety of ongoing clinical cancer research studies, including treatment and prevention trials. The goal of the program participation is to continue translating experience in cooperative group clinical research into expert cancer prevention, cancer control, diagnosis, and treatment (curative, palliative, supportive) for the greater community of central New York (Syracuse and surrounding rural counties). The Syracuse Hematology-Oncology CCOP aims to continue pursuing multi-disciplinary and multi-specialty participation in and awareness of clinical treatment and prevention protocols. The CCOP physicians and staff will continue in efforts to reach the professional and lay publics with current practice in the prevention and management of cancer and to encourage participation in research which has long term benefits for the entire community. The CCOP plans to increase recruitment of minorities to research trials and to maintain its high level of female participation in clinical trials. More specifically, the goal of the Syracuse CCOP physicians and staff is to maintain current levels of participation in clinical treatment trials while increasing the number of registrants on prevention and control trials. In the process of recruitment, the CCOP staff will be able to continue providing health education and screening related to cancer prevention and control.